FFAR4 and nigrostriatal function: A novel target for treatment of PD?

? DESCRIPTION (provided by applicant): Parkinson's disease (PD) is amongst the most prevalent of brain neurodegenerative diseases, and is characterized by movement symptoms including rigidity, tremor, and postural instability. Though an absolute cause of PD has not been discovered, the clinical symptomology evolves due to selective destruction of neurons in the nigrostriatal brain region that are responsible for synthesis of the key neurotransmitter dopamine (DA). Since nigrostriatal neurons regulate coordinated movement in mammals, their destruction as occurs in PD, leads to movement dysfunction. The gold-standard for treatment of PD over the last 4 decades has been administration of the DA precursor L-DOPA, which increases the levels of DA in the nigrostriatal pathway. Importantly, DA synthesis in the brain is regulated by the critical enzyme tyrosine hydroxylase (TH) and as such, approaches that increase TH activity would be expected to increase DA synthesis, and alleviate movement dysfunction. Our laboratory has demonstrated that agonism of the recently discovered free-fatty acid receptor-4 (FFAR4) leads to activation of TH in the rat PC12 cell line that is well-accepted as a model system for neuronal DA synthesis. Additionally, we show that FFAR4 agonism offers significant protection against neurotoxin-mediated cell death in PC12 cells, suggesting that FFAR4 may also have a distinct neuroprotective role. Importantly, FFAR4 is agonized by long-chained saturated fats, including the dietary polyunsaturated omega-3 fatty acids (ω3FA), which have long been known to provide neuroprotective roles in degenerative diseases, including PD. Based on these results, we hypothesize that FFAR4 agonism by ω3FA and synthetic FFAR4 agonists will lead to TH activation and DA synthesis in the rat brain, and may offer neuroprotection in a rat model of PD. This project seeks to test this hypothesis by directly assessing the role of FFAR4 in TH activity and DA synthesis in rat nigrostriatal tissue, and evaluating the neuroprotective role that FFAR4 may play in a rat model of PD. Results of this work will establish a knowledge base towards understanding the physiological role of FFAR4 in nigrostriatal DA neurons and reveal if FFAR4 is a valid physiological target for treatment of PD.

Public health relevance
PUBLIC HEALTH RELEVANCE: Parkinson's disease (PD) is amongst the most prevalent of brain neurodegenerative diseases and results in loss of neurons in the brain that synthesize the neurotransmitter dopamine (DA), which is critical for coordinating movement. Omega-3 fatty acids (ω3FA) have long-since been known to be of benefit in neurodegeneration, and have been shown to be neuroprotective in PD, although the mechanism of this effect remains unknown. Here, we show that in cultured cells, stimulation of free- fatty acid receptor-4 (FFAR4), which is activated by fats including ω3FA, can activate DA-synthesizing machinery and also offers protective effects from neurotoxins that induce PD. The goal of this project is to assess the role of FFAR4 activation in DA synthesis in rat brain and to also determine if FFAR4 activity can be neuroprotective in rat models of PD. Overall, this work will impact our understanding of the involvement of FFAR4 in DA pathways in the brain and could potentially identify FFAR4 as a new target for treatment of PD.